Microscope system for large scale optical imaging of neuronal activity using kilohertz frame rates

Abstract
This project aims to develop the 2P-ActivityScope™, a revolutionary new microscope based on a technological
breakthrough called second-generation Scanned Line Angular Projection (SLAP2) two photon laser scanning
microscopy that was recently developed by Dr. Kaspar Podgorski (Janelia Research Campus, Howard Hughes
Medical Institute, Ashburn, VA). The game-changing innovation in the 2P-ActivityScope is the ability to perform
unparalleled (i) optical imaging of neuronal activity in populations of neurons at subcellular spatial resolution and
temporal resolution in the millisecond range both in vivo and in vitro using a variety of fluorescent indicators (e.g.
voltage, [neurotransmitter]) as well as (ii) high-resolution volumetric calcium imaging of columns of cortical
neurons at 40 Hz in vivo. These capabilities are crucial for ultimately decoding how information is represented
and processed by the billions of densely interconnected neurons comprising the mammalian central nervous
system. Neither contemporary 2-photon microscopes, functional magnetic resonance imaging, inserting
electrodes into the brain, or fiber photometry can serve this need. This project will disseminate and improve upon
the original, lab-built SLAP2 invention to create a commercial product for this important new technology. Based
on pilot work performed at Janelia, it is clear that the 2P-ActivityScope will make a significant impact on the field
of neuroscience research, including advancing studies focused on alterations in CNS circuitry associated with
neurodevelopmental, neuropsychiatric and neurodegenerative disorders. Ultimately, this will result in an
improved basis for developing novel treatment strategies for a wide spectrum of complex brain diseases. In
Phase I we will demonstrate feasibility of this novel technology by developing prototype hardware and software;
work in Phase II will focus on creating the full functionality of the 2P-ActivityScope for commercial release. We
will perform extensive feasibility studies, product validation and usability studies of the 2P-ActivityScope in close
collaboration with Dr. Podgorski and our academic collaboration partners. A competing technology is not
commercially available.

Public health relevance
Narrative This project develops a revolutionary new microscope based on a technological breakthrough called Scanned Line Angular Projection two photon laser scanning microscopy. This microscope will enable optical imaging of neuronal activity at subcellular spatial resolution with a temporal resolution in the millisecond range both in vivo and in vitro using a variety of fluorescent indicators (e.g. voltage and neurotransmitter). As a result, new avenues of neuroscience research will become possible providing promise for the elucidation of novel biological mechanisms associated with human brain disease, and ultimately the basis for developing novel therapies to prevent and treat complex brain diseases.